ROPINIROLE UNDER MULTIPLE DOSING STEADY STATE CONDITIONS IN PARKINSON'S DISEASE

The purpose of this study is to obtain pharmacokinetic assessment of Ropinirole under multiple dosing steady state conditions in Parkinson's disease and to evaluate its long-term safety profile as adjunct to L-Dopa (Sinemet) for up to two years of treatment.